THE RELAXIN RECEPTOR GR/RXFP1 SIGNALING IN LIVER TRANSPLANT ISCHEMIA-REPERFUSION INJURY AND THE INFLAMMATION RESOLUTION

PROJECT SUMMARY/ABSTRACT
Hepatic ischemia/reperfusion injury (IRI), an innate immune-driven inflammation response, is a major obstacle
limiting the success of orthotopic liver transplantation (OLT) in patients with end-stage liver disease and those
with tumors of hepatic origin. Although significant progress has been made in better appreciation of the liver
inflammatory cascade by IR-stress, much less is known about its resolution, which may affect not only the
severity of tissue injury itself but also, more importantly, the long-term outcomes. Recent studies document
striking cytoprotective functions of hrRLX (recombinant human relaxin-2) against IR-stress in mouse OLT models
via hepatocyte glucocorticoid receptor (GR) signaling; while polarizing macrophage activation via Notch1
promoted IRI-OLT resistance. These experimental findings, supported by a clinical evidence of enhanced
GR/Notch1 phenotype needed for IRI resistance in human OLT, prompted to propose that rhRLX may function
as a novel GR agonist and glucocorticoid (GC) mimetic in liver transplantation. Pilot studies also point to anti-
fibrotic functions of the cognate RXFP1 receptor, a GR-independent RLX-2 binding partner. As the conventional
murine OLT model offers a limited translational utility, this project will be dissecting GR – RXFP1 molecular
interplay in mice expressing human RXFP1 gene; as well as testing new concepts of RXFP1-driven hepatic
rejuvenation of discarded human livers during hypothermic machine preservation. A newly discovered divergent
role of GR–RXFP1 signaling axis in the “acute” and “resolution” phase of IRI-OLT inflammation, has prompted
to put forth a novel and heretofore untested overall hypothesis, that: 1/ pharmacological rhRLX-induced GR
enhancement will rescue OLT from acute IR-insult; while 2/ harnessing GR-independent rhRLX signaling via its
cognate receptor, RXFP1, will promote homeostatic/anti-fibrotic functions in the inflammation resolution phase.
Two interlocked aims explore this hypothesis:
Aim 1: Delineate molecular mechanisms of rhRLX – GR hepatocellular protection in OLT (acute IRI-inflammation
phase). Aim 1.1: Test hypothesis that hepatocellular Keap1-dependent Nrf2 signaling is indispensable for rhRLX
– GR axis to prevent DAMPs release and innate inflammation in cold-stored donor livers. Aim 1.2: Test
hypothesis that SIRT1 enhances GR-induced hepatocyte regenerative functions/autophagy in IR-stressed OLT.
Aim 2. Delineate molecular mechanisms of Notch1 / RXFP1 anti-fibrotic functions in OLT (IRI-inflammation
“resolution” phase). Aim 2.1: Test hypothesis that Notch1 (macrophage) – RXFP1 (T cell) cross-regulation is
essential in the resolution of IRI – OLT inflammation. Aim 2.2: Test hypothesis that the activation of human RLX
receptor exerts anti-fibrotic functions in the resolution of IRI-OLT inflammation in humanized RXFP1 “knockin”
mouse system. Aim 2.3: Test hypothesis that activation of RXFP1 receptor during hypothermic machine
preservation attenuates inflammation and rejuvenates discarded human donor livers.

Public health relevance
PROJECT NARRATIVE The shortage and poor quality of donor organs represent major limitations facing liver transplantation, the gold standard of care in patients with end-stage liver disease and those with tumors of hepatic origin. The goal of this project is to improve long-term liver transplant outcomes as well as “rejuvenating” suboptimal hepatic tissue, and promoting homeostasis without late fibrotic pathology. Our findings should facilitate innovative interventions to improve the quality/size of the current organ supply, an absolute imperative for the full realization of success for solid organ transplantation